Endothelial cell transplantation for multi-organ repair to counter radiation injury

Abstract
Exposure to ionizing radiation is often fatal due to acute radiation syndromes (ARS) manifested as
Gastrointestinal-ARS (GI-ARS) and Hematopoietic-ARS (H-ARS). Delayed effects of acute radiation
exposure (DEARE) lead to multi-organ dysfunction syndrome (MODS). A common denominator of
radiation induced multi-organ failure is due to damage to endothelial cells (ECs) and lymphatic ECs,
resulting in leakiness, coagulopathy and inflammation, setting up stage for infection, sclerosis and
tumorigenesis. The molecular basis of radiation-induced EC dysfunction is not well understood. Our goal
is to capitalize on the regenerative function of ECs by intravenously transplanting readily-available, off-the-
shelf, allogeneic human ECs to mitigate ARS, DEARE and MODS. Our central hypothesis is that radiation
damaged blood vessel and lymphatic ECs become dysfunctional and fail to perform their vascular
functions or supply the instructive signals required to promote tissue healing thereby leading to ARS and
DEARE. We propose that transplantation of normal pro-regenerative ECs a day or days after radiation can
rescue the multi-organ defects of radiation-injured ECs and promote scar-free healing. We have shown
that tissue-specific ECs by producing angiocrine growth factors orchestrate the repair of injured organs
without fibrosis. Intravenous transplantation of human ECs restores hematopoietic recovery in sublethally
irradiated rodents and lethally irradiated pigtail macaque non-human primates (NHP) without fibrosis or
tumorigenesis. The Rationale for the proposed experiments is that if we know how to efficiently generate
abundant off-the-shelf GMP-grade human umbilical vein ECs (HUVECs) as a “generic allogeneic vascular
graft”, we will use NHP large animal model radiation models to determine the pharmacokinetics of HUVEC
transplantation to use them as a definitive or intermediary radiation countermeasure to support organ
repair post-radiation. We will test this hypothesis by addressing these Aims: 1) Manufacture of abundant
functional clinical-grade master cell banks of monkey ECs (MUVECs) and human (HUVECs) for
intravenous transplantation. 2) Identify the critical parameters for allogeneic/xenogeneic MUVEC and
HUVEC transplantation into recipient mice to mitigate post-irradiation H-ARS and GI-ARS injury without
provoking fibrosis..3) Employ pigtail macaque NHP radiation models to determine the scheduling, safety
and efficacy of transplanting MUVECs and HUVECs to rejuvenate vascular niche for multi-organ repair
without scarring. Completion of the proposed studies will enable therapeutic use of allogeneic off-the-shelf
“human ECs” that transiently home to the disrupted vascular beds of irradiated organs restoring
angiogenesis and vascular niche functions promoting organ repair, scarring. The success of these studies
will provide for a readily available medical counter measure (MCM) for the treatment of acute and chronic
radiation syndromes preventing life threatening complications.
1

Public health relevance
Project Narrative A common feature of radiation damage is injury to the cells lining blood vessels, endothelial cells (ECs) and lymphatic ECs and we have evidence that transplanting ECs into animals injured by radiation will promote repair and increase survival and also enables other therapies such as bone marrow transplantation to work better. We have developed the necessary methods to engineer clinical grade human ECs and in the hope to advance towards eventual clinical use, we have proposed studied to transplant human ECs into lethally irradiated rodents and most importantly into large animal models of lethally irradiated nonhuman primates so that this approach can next be tested according to FDA guidelines. We hope that eventually human ECs generated by our approach will be frozen, banked for delivery to any destination where people have been exposed to radiation to improve their quality of life and survival.